DEVELOPMENT OF TOLL-LIKE RECEPTOR AGONISTS TO STRENGTHEN SUBLINGUAL VACCINES.

The contract supports the development of a vaccine adjuvant for sublingual use. The adjuvant development activities will occur within the context of an influenza vaccine.